North Texas ADRC - Data Management and Statistical Core

Data Management, Informatics, and Statistics (DMIS) Core
There is great need to advance the use of multimodal data visualization and analyses in ADRD.
In particular, the field has increasingly used novel digital biomarkers such as voice, electronic
health record, and smart phone data, along with an exponential increase in molecular data
outputs. There is a critical need for a comprehensive infrastructure and services to support and
assess these novel biomarkers. Beyond the infrastructure, there also remain critical gaps in
harmonization, quality assurance, and assessing for bias to ensure the quality, accessibility, and
usability of multimodal longitudinal data. Recent advances in advances in AD research
methodologies, data sciences, AI applications and the wide data-sharing and open-science
requirements necessitate a core that will be able to carry out a highly sophisticated and diverse
set of activities. To bridge these gaps, we bring together a highly experienced and specialized
team capable of centralizing the data, statistical, and informatics needs. The NT-ADRC Data
Management, Informatics, and Statistics (DMIS) core leverages diverse expertise with robust
informatics, statistics, and clinical and research data warehousing and resources to achieve the
DMIS core overall aim to provide the data, statistical, and informatics infrastructure for NT-
ADRC investigators and developmental projects, facilitate data sharing and dissemination, and
provide training and support to the Center Research Education Component (REC) scholars. The
DMIS core will facilitate the sharing of data with the National Alzheimer’s Coordinating Center
(NACC) and other ADRCs and will serve as a unifying node of our Cores providing diverse data
science and informatic approaches to NT-ADRC investigators and internal or external
collaborators. Led by a highly experienced and scientifically diverse team, this core will: (1)
Develop and maintain data management and visualization infrastructure (ADExplorer along
with a Participant Management Database) for the NT-ADRC to facilitate participant
identification, recruitment, and management; electronic data capture; integration of EHR data;
and biospecimen management while supporting data requests and sharing with NACC, SCAN,
NCRAD and other local, regional and national initiatives; (2) Provide statistical support in study
design, and data analysis for NT-ADRC and affiliated investigators; (3) Provide specialized data
science and informatics support of the NT-ADRC and affiliated investigators; and (4) Provide
training and educational opportunities for Research Education Component (REC) scholars and
NT-ADRC and affiliated investigators.